Role of Developmental Signaling Pathways in Maintenance of Spinal Discs

PROJECT SUMMARY/ ABSTRACT
Aging is a significant risk factor for the onset of several degenerative diseases, including spinal or
intervertebral disc (IVD) degeneration and associated chronic back pain. IVD degeneration and chronic back
pain are top neurological disorders and substantial financial burden, but with no therapy or cure. Each IVD has
a central core of nucleus pulposus (NP), surrounded by orthogonal layers of annulus fibrosus (AF), together
sandwiched between a pair of endplates that connect the IVD to the vertebral bodies. Much remains to be
learned about the critical regulators of IVD growth, maturation, and maintenance, and whether their loss with
age results in IVD pathologies. We will use conditional genetic mouse models, lineage tracing, heterochronic
IVD organ culture, analysis of human disc samples, and unbiased approaches of high throughput
transcriptomics to identify crucial developmental regulators', including sonic hedgehog (SHH), in IVD
maintenance to fill in these gaps. Our central hypothesis is that Shh-expression by the NP cells is essential for
growth and maturation of the IVD, and its age-related loss leads to the IVD pathologies. The expression of
SHH signaling ligand by the notochord is crucial for embryogenesis. Previously, we showed that postnatal NP
cells continue to express SHH, and SHH signaling regulates NP cell proliferation and ECM production by NP
and AF. Though all NP cells are descendants of Shh-expressing notochord cells, our preliminary data reveals
that most of them turn-off Shh expression after birth. Besides, age-related decline in Shh expression is
associated with terminal differentiation of NP cells into multinucleated syncytium and subsequent loss along
with the declined expression of ECM proteins that are important for IVD function. Our preliminary data also
show that conditional targeting of Shh in adult mice accelerates IVD aging, along with the loss of NP cells,
providing the logical premise for this new project. These data indicate that SHH signaling is crucial; however,
we do not know its precise function during growth and maturation and whether it is critical for aging IVDs. Aim
1 will test the hypothesis that SHH is a critical signaling pathway and its downstream regulators play a distinct
role during infancy and maturation, and its loss causes IVD pathologies. Aim 2 will test the hypothesis
that Shh-expressing NP cells are the progenitor cells, and the stochastic expression of Shh regulates all NP
cells' molecular heterogeneity. Aim 3 will investigate the beneficial effects of SHH signaling for delaying aging.
We expect that the completion of this study will provide insights into the role of SHH as a critical regulator of
growth and maturation of the IVD and identify avenues for targeting such molecules to reverse or delay the
aging process and improve the quality of life of the aging population.

Public health relevance
PROJECT NARRATIVE Aging is a major risk factor for spinal disc degeneration and associated chronic back pain, a significant disease burden but with no effective treatments. Understanding the molecular and cellular basis of disc development and age-associated changes will help develop therapeutics for disc pathologies. The proposed study aims to understand the role of crucial developmental signaling pathways in postnatal disc growth and maintenance and test its beneficial potential in preventing and reversing age-associated degenerative changes in the disc.